Advancing Pantothenate Kinase Activation Therapy

Abstract
Coenzyme A (CoA) is an essential cellular cofactor that carries carboxylic acid substrates in key metabolic
pathways, including the citric acid cycle, sterol biosynthesis, amino acid metabolism, and fatty acid
biosynthesis and oxidation. The pantothenate kinases (PANK) phosphorylates pantothenate (vitamin B5) in the
first and rate-limiting step of the CoA biosynthetic pathway. Three genes encode four PANK isoforms in
humans, PANK1α, 1β, 2, and 3, and the isoform expression levels in different tissues and sub-cellular
compartments, together with potent feedback inhibition by CoA thioesters, control the intracellular CoA
concentrations. Mutations in PANK2 are directly causative for Pantothenate Kinase-Associated
Neurodegeneration (PKAN). PKAN, formerly called Hallervorden-Spatz syndrome, is an autosomal recessive
movement disorder with onset in childhood and is characterized by neurodegeneration, progressive
parkinsonism, and brain iron accumulation (NBIA). Our efforts began with the discovery of PZ-2891, an
allosteric activator of PANK3 that counteracts the allosteric inhibition by acetyl CoA. PZ-2891 elevates CoA in
cells, crosses the blood-brain barrier, and elevates CoA in the brains of mice. Most importantly, PZ-2891
rescues a conditional PKAN mouse model with CoA deficiency in neurons and corrects the growth defect,
improves the movement disorder, and extends survival substantially. Through a major investment into this
program, we were able to rapidly advance the development of PZ PANK activators, leading to the nomination
of BBP-671 as a clinical candidate, which advanced into Phase I clinical trials. BBP-671 development has
recently been stopped at this stage due to variable pharmacokinetics in humans.
Here, using the BBP-671 roadmap, we propose to develop the next generation of PANK activators that
overcome the pharmacokinetic limitations of BBP-671 using an iterative cycle of structure and metabolism-
guided drug design. New modulators will be synthesized and evaluated in a staged testing cascade. Studies
will also further explore the biochemical and cellular basis of PANK activation by PZ modulators, and we will
test the hypothesis that activation by PZ modulators is associated with PANK isoform selectivity and overall
affinity. Pharmacokinetic/Pharmacodynamic studies in mice will be used to study oral bioavailability, blood-
brain penetration, and efficacy of new activators. The most efficacious compounds will then be tested in the
SynCre+ PANK1 and PANK2 neuronal knockout mice for their ability to improve the PKAN phenotype. At this
point, we aim to declare a new late-stage preclinical lead suitable for advancement.

Public health relevance
Narrative We aim to develop compounds that will elevate Coenzyme A levels in the brain to treat PKAN, formerly known as Hallorverden-Spatz disease, a catastrophic rare inherited neurological movement disorder in children caused by autosomal recessive mutations in the PANK2 gene. To do so, we will use structure and metabolism-guided drug design to synthesize the next generation of pantothenate kinase activators.